IGF::OT::IGF, FY 2014, POP 5/2/2014-5/1/2015, N01DA-14-8916, Non-Clinical ADME Studies, Option Quantity 5 exercised 5 times.

The Contractor shall conduct non-clinical Absorption, Metabolism, Distribution, and Elimination (ADME) studies, protein binding studies, and analytical services in support of NIDA medication development program.